Adapting and evaluating an integrated intervention for adolescent substance use and pain during oral surgery

PROJECT SUMMARY
Substance use (SU) is most commonly initiated during adolescence. Earlier age of onset is associated with
more significant and persistent adverse outcomes, such as impaired psychosocial and educational functioning,
myriad health consequences, and long-term struggles with SU and addiction — underscoring the critical need
to identify and intervene on SU as early as possible. Thus, the public health need to increase availability and
quality of evidence-based interventions for adolescents (ADOL) who are using substances cannot be
overstated, especially in Rhode Island where ADOL are not receiving substance use disorder treatment that
they need at higher than national averages. This proposal not only aims to increase access to interventions for
ADOL using substances but also improve brief interventions for ADOL by co-addressing pain in an innovative
pre-surgical context. Acutely painful procedures, such as wisdom tooth extraction, are an opportune time to
identify SU behaviors and engage ADOL in brief intervention due to shared risk factors between SU and pain
and the potential for exposure to prescription opioids. Aim 1 is to adapt and integrate pre-existing evidence-
based brief interventions for adolescent SU (MET-CBT) and acute pain coping (CBT) into a pre-surgical brief
intervention (PS-BI) for ADOL and their parents. PS-BI will be developed by the PI and her interdisciplinary
mentorship team in conjunction with feedback from key informants (e.g. ADOL, parents, and dental providers).
Aim 2 will evaluate PS-BI in a pilot randomized controlled trial (RCT) versus a control condition of current best
practice among ADOL (age 15-18 years) who use cannabis (and other substances) undergoing wisdom tooth
extraction. Key outcomes for the pilot RCT (Aim 2) are feasibility and acceptability. Ecological momentary
assessment (EMA) methods will be used to elucidate associations between pain, craving, and SU (Aim 3) and
explore if those associations are attenuated by PS-BI (Exploratory aim). This will be the first test of within-
person associations of hypothesized precursors (e.g., pain intensity), substance craving, and use in the
perioperative context among ADOL who use substances. A highly structured training plan will ensure execution
of the proposed research aims. Specifically, the PI will receive advanced training in (1) intervention
development and clinical trial methods, (2) integrated SU interventions for ADOL, (3) EMA, (4) advanced
statistical approaches, including longitudinal data analysis, and (5) mentoring and leadership skills to combine
with her expertise in pediatric psychology, interdisciplinary collaboration in medical settings, and pediatric pain.
Training will be guided by a stellar mentorship team with highly relevant expertise and long-standing track
records of successful mentorship. The proposed research and training plan is further supported by the rich
training environment at the Center for Alcohol and Addiction Studies at Brown University. Through this K23, the
PI will obtain specialized training to launch her independent research focused on developing, evaluating, and
implementing innovative interventions for adolescent SU and pain in integrated care settings.

Public health relevance
PROJECT NARRATIVE Substance use among adolescents (ADOL) is prevalent, yet grossly undertreated. Wisdom tooth extraction is a common, acutely painful procedure for ADOL that represents an opportune time to identify ADOL substance use and engage ADOL in brief intervention due to shared risk factors between SU and pain, the potential for exposure to prescription opioids for pain management, and because substance use is associated with increased risk for post-operative complications. This study aims to adapt and evaluate a novel, scalable pre- surgical brief intervention for ADOL with substance use undergoing oral surgery (i.e. wisdom tooth extraction) that dually targets substance use and pain coping.